Tissue structure and mechanical function relationships of the human temporomandibular lateral capsule-ligament: Investigation of sexual and racial dimorphisms

Project Summary/Abstract
As many as 10 million adults in the United States have temporomandibular disorders (TMDs). Females
experience TMDs at higher rates compared to males and African Americans have higher TMD incidence, yet
lower prevalence compared to white Americans. Despite these findings, etiological mechanisms contributing to
prevalence and incidence disparities by sex and race are largely unknown. Given our recent reports on sexual
dimorphisms in incremental tensile stiffness and fixed charge density of the human temporomandibular disc, it
is hypothesized that additional sexual dimorphisms may exist in properties of the temporomandibular joint (TMJ).
Similar differences are also hypothesized to exist between racial groups, although this possibility has not yet
been explored, which may limit research translational confidence across racial groups. The lateral capsule-
ligament (LCL) complex, which spans the temporal bone and mandibular condyle, could impact
temporomandibular disc derangement (TMDD) risk through a ‘loose ligament’ mechanism affecting joint
articulation postulated in prior literature. Furthermore, sex- and race-specific differences in potential risk and
resiliency factors may contribute to differential risk of TMDD development and observed TMD prevalence and
incidence disparities. Our long-term goal is to enable individualized TMDD risk assessment to increase
applicability of generated risk estimates. The objective of this study is to describe sex- and race-specific
mechano-chemical LCL complex properties to investigate potential contributions to TMD disparities
between sexes and racial groups. The central hypothesis is that TMJ properties observed in females and
African Americans will be associated with higher risk of TMDD development compared to those of males and
white Americans. The proposed studies will enable the determination of sex- and race-specific differences in
potential mechanical and chemical risk factors for TMD development (Aims 1 and 2). This determination will
contribute to a better understanding of TMJ properties across diverse populations and is crucial to enabling
understanding of TMD incidence and prevalence disparities. Finite element models will also be used to
investigate how differences between sexes and racial groups impact the temporomandibular loading
environment, which will be developed, refined, and interpreted during the independent phase (Aim 3). This
proposal aims to further development of scientific expertise and skill acquisition in temporomandibular and
craniofacial biomechanics, with a plan to transition from mentored post-doctoral fellowship to independent
faculty. NIH T32 training and professional development resources, joint resources and network of the Clemson-
MUSC Bioengineering program, and the Clemson University Pathways Mentoring Program provide an ideal
inter-disciplinary training environment to prepare for and transition to independence following the postdoctoral
fellowship period.

Public health relevance
Project Narrative Females experience temporomandibular disorders at higher rates compared to males, and African Americans have higher temporomandibular disorder incidence, yet lower prevalence compared to white Americans; the causes of these sex and race disparities remain largely unknown. The goal of the proposed study is to investigate how sex- and race-specific differences in human temporomandibular lateral capsule-ligament (LCL) complex properties may affect the temporomandibular joint loading environment. Sex- and race-specific differences in human LCL complex properties could result in a temporomandibular loading environment with variable resiliency and sensitivity to pathologic displacements between sexes and racial groups, creating disparities in temporomandibular joint disorder incidence and prevalence.